Mapping Age-Related Changes in the Lung

ABSTRACT
Aging is associated with increased prevalence of lung diseases, such as idiopathic pulmonary fibrosis (IPF),
chronic obstructive pulmonary disease (COPD), and acute lung injury (ALI), however, the molecular
mechanisms of the aging process that contribute to the pathogenesis of age-related lung diseases have not
been completely elucidated.
At a cellular level, only limited knowledge of the factors that define healthy aging of different lung cells is
available. Based on the above, we propose to create an atlas of human aging lung (AHAL) consisting of
transcriptomic maps of individual lung cell types. This will fill an existing knowledge gap and provide a rich
resource for future research. Transcriptional differences might reflect genomic instability, alterations in stress
responses and enrichment of markers of mitochondrial dysfunction, senescence and SASP. We also
investigate the hypothesis that defective mitophagy is interconnected with senescence in the aging lung.
Based on ours and other studies, we hypothesize that primary autocrine age-related senescence differs
transcriptionally from the secondary paracrine senescence program observed in age-related lung diseases
such as IPF
We are proposing 3 independent aims to define age-related changes in the lung
Aim 1: To map and characterize transcriptomic age-related changes in human lungs. We will perform
single cell RNA sequence (scRNAseq) and bulk RNA sequence (RNAseq) from healthy young and aged
human lungs and build a comprehensive atlas of transcriptomic changes in each lung cell type, as well as cell
population shifts in aging lungs. In order to understand how chronological and functional ages differ, we will
also compare the identified age-related gene signatures with those of the upper and lower lobe in IPF, an age-
related lung disease. Data, results and lung cellular and transcriptome maps will be made publicly available
through a cloud based comprehensive web portal that we will develop.
Aim 2. To characterize the role of mitophagy in the aging lung and the senescence phenotype. We will
investigate the hypotheses that augmenting mitophagy attenuates mitochondrial dysfunction in the aging lung
and modulates the senescence phenotype. We have identified the mitochondrial deubiquitinase USP30, a
negative regulator of mitophagy, as a key factor for mitophagy decline. As a proof of concept, we will
investigate the potential pathogenic role of USP30 in the development of cell senescence using primary murine
and human cells and USP30-/- mice.
Aim 3. To identify senescence-related changes in aging lung cell compartments. We will examine how
aging senescent cells and their SASP repertoire differ between cell compartments and contribute to tissue
remodeling after injury. We will perform scRNAseq in isolated senescent cells from young and aged lungs and
characterize their cell-specific senescent transcriptome. We will also investigate if age-related senescence is
similar to senescence observed in cells from IPF lungs.!

Public health relevance
Narrative: Aging is natural and inevitable process characterized by decline of vital functions and lower capacity to respond to stress. Aging is associated with increased susceptibility to a diverse set of diseases. The lung is not the exception, and the prevalence of chronic lung diseases such as chronic obstructive pulmonary disease and Idiopathic Pulmonary Fibrosis increases significantly with age. There is limited knowledge of the molecular factors that define healthy aging in the lung. Our goal is to create an atlas of human aging lung consisting of gene expression maps of individual lung cell types. We will evaluate with special emphasis alterations in the mitochondria and senescence. These studies will fill an existing knowledge gap and provide a rich resource for future research in lung aging.